Magnetic resonance biomarkers of muscle degeneration in patients with rotator cuff tears

PROJECT ABSTRACT
Histological studies showed that the degenerative process following rotator cuff tears goes beyond the mere
accumulation of fat and includes diminished functional contractile tissue and altered perfusion. Histological
measures are limited in clinical studies due to the invasive methods (biopsy) necessary to sample tissue.
Quantitative magnetic resonance (MR) imaging and spectroscopy can measure the degenerative process in
skeletal muscles, track disease progression and therapeutic efficacy. MR imaging-based Blood Oxygen Level-
Dependent (MRI-BOLD) and 31phosphorus MR spectroscopy (31P-MRS) are reliable estimates of muscle
microvascular function and energetic status, which are makers of muscle function and quality. Alterations of MRI-
BOLD and 31P-MRS are related to lower extremity weakness and decreased gait performance associated with
aging, as well as the degeneration associated with pathological disorders of skeletal muscles. Thus, MRI-BOLD
and 31P-MRS offer advantages over measures of muscle function and quality that require tissue sampling. These
markers may enhance the mechanistic understanding of the degenerative process following rotator cuff tendon
tears, and may provide quantitative measures for treatment efficacy, which is of the utmost importance
considering the recent advent of biological augmented treatment approaches. Ultimately, they can positively
impact the care of over 4.5 million Americans who seek treatment for rotator cuff tears each year. This project
will use MR-derived markers (MRI-BOLD, 31P-MRS) to investigate microvascular function and energetic status
of the supraspinatus in 30 individuals with full-thickness supraspinatus tears, the most commonly torn rotator
cuff tendon. Thirty age and sex-matched individuals without shoulder pain or imaging evidence of rotator cuff
tears will be recruited as controls. This project has three specific aims: 1) Develop a dynamometer to measure
shoulder abduction force in real-time during MR scans; 2) Test the hypothesis that post-contractile MRI-BOLD
response and energetic status evaluated with 31P-MRS of the supraspinatus differ between patients with full-
thickness supraspinatus tendon tears versus control individuals; and 3) Test the hypothesis that the MRI-BOLD
response and energetic status of the supraspinatus predict shoulder function and abduction strength in patients
with full-thickness supraspinatus tendon tears, after accounting for the variance predicted by sex, pain, and fat
accumulation. Completing this study will advance the field of quantitative imaging by providing non-invasive
measures of muscle vascularity and energetic status in individuals with full-thickness supraspinatus tendon tears.
These measures will advance the understanding of the degenerative mechanisms after rotator cuff tendon tears.
Future clinical research will evaluate the impact of supraspinatus degeneration/regeneration on patients’
symptoms and the efficacy of promising treatment approaches. Ultimately, this innovative proposal will lay the
foundation to promote a paradigm shift in the way we approach and treat rotator cuff tears.

Public health relevance
PROJECT NARRATIVE Muscle biopsies are the gold standard for studying muscle degeneration associated with rotator cuff tears, but they are invasive and have limited clinical applications. In this project, we propose to use magnetic resonance imaging and spectroscopy to accurately and non-invasively measure muscle health in patients with rotator cuff tear. This project has the potential to validate quantitative non-invasive outcome measures to assess the pathological processes associated with rotator cuff tears, which can be used to measure treatment efficacy.